Guidelines for the management of acute low back pain

Project Summary
The World Health Organization (WHO) recently reported that low back pain (LBP) is the leading cause
of disability globally; among musculoskeletal conditions LBP accounts for the highest prevalence. One
estimate indicates that at some point in their lives, up to 84% of adults will suffer from LBP. Although most
patients with acute low back pain (ALBP) experience rapid improvement, some patients develop persistent,
disabling symptoms. Management of ALBP has been characterized by variability in use of imaging and
treatments, including frequent use of opioids. While clinical practice guidelines (CPGs) recommend judicious
use of opioids, overprescribing remains an important area of concern, including serious adverse events such
as overdose and opioid use disorder. In 2017, an estimated 47,600 Americans died from opioid overdose;
17,000 from prescription opioids. Given the high prevalence of ALBP and the potential to improve health
outcomes through evidence-based approaches to evaluation and management, the U.S. Food and Drug
Administration (FDA) identified the development of CPGs for treatment of ALBP as a priority. The objective of
this proposal is to assemble a highly experienced, multidisciplinary team of clinical investigators,
methodologists, providers, healthcare systems, payers, and patient representatives to conduct a rigorous
systematic review (SR) of the literature about management of ALBP; derive evidence-based clinical practice
guidelines (CPGs); conduct a wide-ranging dissemination and implementation campaign; and evaluate the
impact of the CPGs on knowledge, uptake, prescribing behavior, and short-term outcomes.
Our specific aims are: Specific Aim #1. [Phase 1a] Following rigorous, accepted methodology for transparency
and objectivity, conduct an evidence-based systematic review of the literature on the evaluation and
management of ALBP, including the benefits and harms of use of opioids. Specific Aim #2. [Phase 1b] Utilizing
the SR, develop an evidence-based CPG using a transparent process. Specific Aim #3. [Phase 2] Disseminate
and implement the CPG, through implementation tools; publications and presentations to conferences,
specialty societies, healthcare systems, payers, and patient/advocacy groups; and through webinars, social
media posts, podcasts, a provider app, and a patient journey map. Specific Aim #4. [Phase 3] Evaluate the
impact of the CPG on adoption, and on changes in knowledge, pain management, prescribing practices, and
measures of utilization. Describe and analyze barriers to and facilitators of CPG implementation. In
accomplishing these aims, we will produce a CPG for management of ALBP that will contribute to the goals of
the FDA to provide indication-specific, appropriate prescribing information for pharmacologic and non-
pharmacologic treatments to the provider communities, while reducing opioid misuse and abuse. We will
establish and document rigorous and reproducible dissemination and implementation protocols and practices
that can be used for future CPG projects.

Public health relevance
Project Narrative This project will advance knowledge about the management of acute low back pain (ALBP) and, based on best evidence derived from rigorous methods, will generate clinical practice guidelines (CPGs) for treatment approaches, including use of opioid analgesics. Providers, healthcare systems, payers, and patients will have access to the most current evidence about and recommendations for management of ALBP. This project can directly impact and mitigate the current public health crisis of the significant increase in opioid use disorder (OUD) and opioid-related deaths from overdose.